Biostatistics and Bioinformatics

The research proposals in this SPORE encompass a broad range of activities, including studies with cell lines, animal models, and clinical trials. These studies will generate different types of data. Properly designing and analyzing such a wide variety of studies will require a variety of statistical and bioinformatics techniques Data and information must flow smoothly between projects. Data quality and integrity must be ensured by using data audit and backup procedures. Also needed is an efficient interface between the computational biology and data storage facilities provided by the SPORE Core C (Pathology and Data Management Core), particularly forthe large amounts of microarray and proteomics expression profiling information. To meet these needs, the Biostatistics and Bioinformatics Core brings together several biostatisticians, bioinformaticians and analysts with expertise in a variety of statistical and bioinformatics disciplines. Placing these individuals within the Biostatistics and Bioinformatics Core (rather than in the individual Projects) strengthens the ability of the Projects to interact effectively. This resource also has the flexibility to match personnel to the evolving biostatistics and bioinformatics needs of the SPORE projects. The Biostatistics and Bioinformatics Core will provide expertise in study design and data analysis to all Projects and Cores. The specific aims of the Biostatistics and Bioinformatics Core are to: The specific aims of the Biostatistics and Bioinformatics Core are to: 1. Provide guidance in the design and conduct of clinical trials and other experiments arising from the ongoing research of the SPORE. 2. Provide the innovative and tailored statistical modeling, simulation techniques, and data analyses needed by the Projects, Developmental Research and Career Development Projects, and other Cores to achieve their specific aims. 3. Ensure that the results of all Projects are based on well-designed experiments and are appropriately interpreted.